Training in the Science of Health Development

Summary The Ohio State University College of Nursing T32 (7/1/20-6/30-25) provides research training on health development. The specific aims of the training program are to: 1) prepare trainees to conduct rigorous research with a particular emphasis on health development during sensitive and critical periods of health development across the life span; 2) prepare trainees to develop and implement ethical research; 3) prepare trainees to successfully translate the science of health development into clinical practice and health policy in order to improve health outcomes; and 4) increase the number and strengthen the scientific foundation of early career nurse scientists. Our aim for this administrative supplement is to: Add 1 predoctoral and 1 postdoctoral trainee, each with a research focus on the examination of the effect of lifecourse exposures and health determinants on Alzheimer’s disease (AD) and Alzheimer’s disease related dementias (ADRD), including AD and ADRD risk and cognitive changes in later life. This additional aim will address the specific review criteria of NOT-AG-20-034 in these ways: 1) The proposed additional trainees would work within the scope of the active training grant, taking the same courses but with the specific mentorship assignment to training faculty with expertise in aging, AD/ ADRD, exposures to adverse events across the lifecourse, health determinants, and health outcomes (e.g. pain perception, social isolation, and impaired cognitive function); 2) The work will focus on predictors, mechanisms, and mediators of AD/ADRD; and 3) The work of the trainees will build on faculty expertise and on-going research, leading to future studies (F31 and K applications; R awards) to further investigate relationships and develop interventions to mediate the effects of lifecourse adversities and health determinants on the occurrence and/or severity of AD/ADRD. The pre- and postdoctoral trainees selected for funding supported by this supplement will have a unique opportunity to work within a health development framework to promote optimal outcomes for a significant health concern ? Alzheimer’s disease and Alzheimer’s disease-related dementia. Through a combination of didactic coursework, directed research residencies, mentorship, skill-building workshops, research seminars, and independent research projects, trainees will develop competencies to conduct state-of-the-art research in the science of health development focused on AD/ADRD. Senior research mentors with active, federally-funded research programs in AD/ADRD related to health determinants, mechanistic processes, and/or health outcomes, will guide trainees in their studies and work closely with trainees to study how health determinants intersect to influence health development in AD/ADRD, and to use this knowledge to examine ways to optimize health outcomes.

Public health relevance
Narrative This supplement application requests support for one pre- and one postdoctoral research trainee to build careers focused on Alzheimer’s disease and Alzheimer’s disease related dementias.